Improving the platelet-mediated immune checkpoint inhibitor delivery for treating triple-negative breast cancer

Project Summary
Despite the great success of immune checkpoint inhibitors in treating a subset of cancer patients by blocking
PD1/PDL1 pathway, the treatment outcomes in triple-negative breast cancer (TNBC) remain dismal partially due
to the immunosuppressive microenvironment and impaired T cell infiltration in the TNBC. We recently developed
a platelet-mediated immune checkpoint inhibitor delivery system (designated P-aPDL1) that could efficiently
target the post-surgical tumor site and bioresponsively release aPDL1 in the format of platelet-derived
microparticles upon the activation of platelets at the tumor site. We have demonstrated the enhanced treatment
efficacy against post-surgical B16F10 melanoma and 4T1 TNBC tumor recurrence, while treatment outcomes
on the intact non-immunogenic 4T1 TNBC without pre-treatment with surgery remain to be improved. In this
proposal, we intend to develop multi-faceted strategies to enhance the treatment efficacy of P-aPDL1 against
TNBC through (1) increasing the tumor-selective P-aPDL1 accumulation by triggering a local thrombus formation
at the TNBC site; and (2) modulating the immunosuppressive tumor microenvironment through depleting tumor-
associated macrophages (TAMs). Specifically, in AIM 1, we will apply a truncated tissue factor-RGD (tTF-RGD)
peritumorally or systemically to trigger the local thrombus formation in the tumor tissue and attract the
accumulation of P-aPDL1. Both 4T1 TNBC primary and metastatic tumors will be used to evaluate the treatment
efficacy. In AIM 2, we will intratumorally inject TAMs-depleting nanoparticles (PLX-NP) to modulate the
immunosuppressive microenvironment to facilitate the infiltration of effector T cells to synergize with P-aPDL1
for enhanced treatment efficacy against TNBC. In AIM 3, the combination treatment strategies identified in AIM
1-2 will be evaluated on a fully validated patient-derived xenograft (PDX) TNBC humanized mouse model. This
proposal will develop a suite of new combination immunotherapy strategies to increase the anti-tumor efficacy
against TNBC and provide significant insights into advancing the current immunotherapeutics for treating other
non-immunogenic tumors in the clinic.

Public health relevance
Public Health Relevance Statement Immunotherapy with immune checkpoint inhibitors has achieved great success in treating various types of cancer clinically, while its treatment efficacy on triple-negative breast cancer (TNBC) remains dismal. In this proposal, we will develop combination strategies to facilitate the treatment efficacy of platelet-mediated immune checkpoint inhibitor delivery systems against TNBC. The successful completion of this proposal will develop a suite of new combination immunotherapy strategies to increase the anti-tumor efficacy against TNBC and provide significant insights into advancing the current immunotherapeutics for treating other non-immunogenic tumors in the clinic.